Orchestrating Tendon Regeneration through Nanoparticle Drug Delivery

Project Summary
Tendon regeneration following acute injury is marred by a fibrotic healing response that impairs complete
functional recovery. Despite the frequency of injuries and complications associated with poor healing, including
re-injury and limited range of motion, no pharmacological approaches exist to improve tendon healing. While
several interventions have been proposed, systemic treatments lack tendon specificity, resulting in poor tendon
biodistribution and off-target toxicities. We recently made the serendipitous discovery via spatial transcriptomic
profiling that inflammatory tissue at the healing tendon site is enriched for expression of Acp5, the gene
encoding tartrate-resistant acid phosphatase (TRAP), and our preliminary data show robust TRAP activity in
the healing tendon. Therefore, to enable tendon targeting, we have leveraged our TRAP binding peptide (TBP)
functionalized nanoparticle (NP) drug delivery system (DDS) comprised of poly(styrene-alt-maleic anhydride)-
b-poly(styrene) (PSMA-PS) to successfully target extracellular matrix TRAP deposited in the healing tendon.
After accumulation at the tendon, NPs are primarily taken up by macrophages (M), critical regulators of the
fibrotic healing response in adult tendons, and the insufficient matrix elaboration phenotype observed in aged
tendon healing. As such, we will optimize and leverage our promising TBP-NP system to test the central
hypothesis that TBP-NPs can be tuned to enable efficient tendon targeting at various points during healing to
enhance tendon regeneration in adult and aged models. We will develop this innovative platform technology
and test this hypothesis through three aims: Aim 1. Maximize spatiotemporal tendon targeting and delineate
cellular targets of TBP-NPs, Aim 2. Establish the efficacy of TBP-NP drug delivery to promote adult tendon
healing; Aim 3. Establish the efficacy of TBP-NP drug delivery to promote aged tendon healing. Successful
completion of these studies will establish a novel nanoparticle-mediate delivery system to target the healing
tendon with high efficiency and efficacy, which achieves tendon healing by modulating macrophage
polarization. In sum, this work will substantially enhance the translational feasibility of non-invasive
pharmacotherapies for tendon regeneration.

Public health relevance
Narrative Following injury, tendons heal via formation of persistent, fibrotic scar tissue which impairs functional restoration, however, no pharmacological approaches exist to improve tendon healing. While several interventions have been proposed, systemic treatments lack tendon specificity. To address this gap, we have developed an innovative nanoparticle drug delivery system to specifically target the healing tendon to promote healing in normal and aged models, which achieves tendon healing by modulating macrophage functions.